Improving lung cancer surgery with an intraoperative, tumor-targeted, activatable fluorescent imaging agent

PROJECT SUMMARY/ABSTRACT
More than 228,000 people in the United States will receive a lung cancer diagnosis this year. Only 14%-49% of
early-stage patients survive at least 5 years after their diagnosis, and the survival rates fall below 5% for
patients with advanced-stage IIIB or IV. Tumor recurrence after resection is a critical factor influencing these
poor prognoses. If any cancerous tissue is left behind during surgery, the risk of an aggressive tumor
recurrence increases dramatically. These recurrent tumors rapidly spread and negatively impact a patient’s
clinical outlook. Therefore, accurately identifying tumor tissue during surgical resection is crucial. Despite this
need, translating preoperative images into the surgical suite for real-time, precise visualization remains a
challenge; in an intraoperative setting for lung cancer, tissues are often displaced, lungs are deflated, and
blood can obscure the surgical field. Vergent Bioscience, Inc. developed a molecular imaging agent, VGT-309,
to meet this urgent need for improved intraoperative visualization of tumors. This agent is administered as a
single intravenous dose prior to surgery, after which it will bind to upregulated cathepsins in the cancerous
tissue, become activated, and fluoresce. Commercially available near-infrared (NIR) imaging systems can then
be used during surgery to illuminate the tumor and enable surgeons to precisely identify and remove tumor
margins, ensuring no cancerous tissue is left behind. VGT-309 has a wide post-dose imaging window and can
be seamlessly integrated into existing surgical workflows without requiring additional training or equipment.
Extensive preclinical safety, efficacy, and dosing studies have validated the use of VGT-309 to facilitate the
resection of a variety of solid tumor types. A Phase 1 randomized, double-blind, placebo-controlled, single
ascending dose study in healthy subjects was completed in early 2021 to evaluate the safety, tolerability, and
pharmacokinetics of VGT-309. All four doses were safe and well-tolerated during this trial, so a starting dose of
0.05mg/kg was selected for patients with lung cancer who are currently enrolled in an ongoing Phase 2 clinical
trial in Australia to determine optimal VGT-309 dose and timing. During the present Direct to Phase II
application, Vergent will 1) manufacture VGT-309 drug product following Current Good Manufacturing
Practices, and 2) collaborate with the Hospital of the University of Pennsylvania to evaluate this agent in a
Phase 2, open-label study to assess its safety, tolerability, and efficacy in 35 patients scheduled to undergo
standard of care surgical resection for suspected or proven lung cancer. Once successfully validated in our
Phase 2 clinical trial, VGT-309 will be evaluated in larger, multi-site Phase 2b and Phase 3 studies. Ultimately,
we plan to expand the use of this fluorescent, activatable molecular imaging agent to other solid tumors such
as colorectal, head and neck, ovarian, brain, gastric, and breast. This agent has the potential to transform the
surgical oncology space and optimize clinical outcomes for patients undergoing resection of tumors.

Public health relevance
PROJECT NARRATIVE Lung cancer is the second leading cause of death in the United States, killing more people than colorectal, breast, and prostate cancers combined. Despite the many advances in surgical care and preoperative imaging, surgeons must often rely only on their visual and tactile abilities to distinguish tumor tissue from healthy tissue during surgical resection, which may result in positive tumor margins and higher risks of recurrence. A targeted molecular imaging agent, VGT-309, will be used in a Phase 2 clinical trial to illuminate lung tumor tissue during surgery and facilitate the precise identification of tumor margins, ensuring all cancerous tissue is removed and providing lung cancer patients with an urgently needed intraoperative imaging solution.